Targeting brain tumor initiating cell-specific super-enhancer associated genes to treat glioblastoma

PROJECT SUMMARY
While cancer has traditionally been viewed as a disease process based exclusively on genetic aberrations,
increasing evidence has demonstrated that epigenetic alterations contribute to the pathogenesis and progression
of many types of cancer. One emerging epigenetic driver of cancer is the superenhancer, which is defined as a
cluster of typical enhancers in close genomic proximity. The significance of superenhancers is supported by their
roles in determining cell state and identity through regulation of lineage-specific gene expression, with
enrichment in disease-associated genetic variation. Superenhancers identified from cancer cells identify tumor-
associated genes in a number of cancer types, including multiple brain tumors. Due to the close association
between superenhancer structure and biological function, alterations in disease-specific superenhancers may
reveal insights into the molecular mechanisms of disease pathogenesis.
Glioblastoma is the most common and most aggressive primary brain tumor, with poor responses to all
therapeutic modalities despite intensive research. One major contributor to the poor prognosis of glioblastoma
is the presence of stem-like cancer cells, often called cancer stem cells. Cancer stem cells are functionally
defined by their abilities to self-renew, differentiate, and form tumors upon transplantation. Cancer stem cells
contribute to resistance to radiation and chemotherapy, as well as maintenance of tumor heterogeneity and
angiogenesis. Thus, cancer stem cells have become an important target for the design of novel therapeutic
strategies. To better understand key regulators of glioma stem cell identity, an original super-enhancer screen
identified genes that are epigenetically upregulated in glioma stem cells and for which elevated expression is
associated with poor patient prognosis.
Leveraging chromatin landscape analysis of patient-derived glioblastoma stem cells, I identified putative
superenhancers that are associated with poor patient prognosis. Targeting the genes associated with the
superenhancers revealed a loss of viability, suggesting potential value in this discovery effort. This approach
revealed a cohort of potential super-enhancer associated genes that I propose for further study. I will investigate
the transcription factor network that regulates the expression of these genes including enhancer elements,
transcription factor occupancy, and super-enhancer structure. The second aim will define the role of the
superenhancer-associated genes in glioma cell survival, self-renewal capacity, and tumor formation in both in
vitro and in vivo settings. The third aim will elucidate the molecular mechanism by which these genes promote
tumorigenesis. These approaches will lead to a greater understanding of the epigenetic features that define the
glioma stem cell state and inform the development of novel therapeutics

Public health relevance
Project narrative: Glioblastoma is a lethal brain cancer for which there are currently no successful therapeutic options. Because cancer stem cells are proposed to underlie resistance to traditional treatment options, this proposal seeks to evaluate novel epigenetically regulated genes, which promote survival and self-renewal of cancer stem cells. This endeavor will inform future drug development by delivering the next generation of glioblastoma stem cell specific targets.